Coxiella manipulation of cholesterol in the intracellular niche

PROJECT SUMMARY/ABSTRACT
Coxiella burnetii is the causative agent of human Q fever, a zoonotic disease that can cause a debiliting, flu-
like illness in acute cases, or a life-threatening endocarditis in chronic patients. Q fever patients present with
few distinguishing clinical features, and chronic disease requires a minimum of 18 months of antibiotic
treatment, highlighting the need for new therapeutics. An obligate intracellular pathogen, Coxiella survives
inside a large, lysosome-like parasitophorous vacuole that is essential for bacterial replication and protects the
bacteria from the host immune response. The Coxiella parasitophorous vacuole (CPV) forms through
heterotypic fusion with host endosomes and autophagosomes, a process which also delivers cholesterol to the
CPV membrane. We recently determined that accumulation of host cholesterol in the CPV is toxic to the
bacteria, and hypothesize that Coxiella must deplete CPV cholesterol in order to survive within the host cell.
The objective of this application is to test our hypothesis that Coxiella uses two distinct mechanisms to
manipulate CPV cholesterol. Aim 1 will test the role of membrane contact sites in cholesterol transfer between
the CPV and the host endoplasmic reticulum. Aim 2 will determine the role of putative Coxiella sterol
reductases in modifying CPV cholesterol. At the conclusion of these studies, we will have elucidated how
Coxiella manipulates host cholesterol to maintain the optimal microenvironment for bacterial surivival.

Public health relevance
PROJECT NARRATIVE The obligate intracellular bacterial pathogen Coxiella burnetii is the causative agent of human Q fever. We propose to elucidate the molecular mechanisms behind Coxiella’s unique sensitivity to host cholesterol. Understanding the relationship behind cholesterol and Coxiella’s ability to survive within the host cell will identify novel therapeutic targets.